THE INFLUENCE OF PREGNANCY ON SEIZURE SUSCEPTIBILITY

This project will assess the basic neurochemical changes which accompany normal pregnancy. It has been known for many years that there is a marked reduction in the levels of vitamin B6 in the blood of pregnant women, and that in the pathologic pregnancies preeclampsia and eclampsia, this deficit is even greater. The significance of this observation is that vitamin B6 deficiency is known to be a predisposing factor for the development of seizures, and eclampsia is characterized by generalized seizures which are life-threatening to mother and fetus alike. Vitamin B6 is required for synthesis and degradation of several neurotransmitters including norepinephrine, dopamine, serotonin and Gamma-aminobutyric acid. During vitamin B6 deficiency there is, presumably, an alteration in the functioning of these neurotransmitter pathways, and it is this which results in predisposition to seizures. An enzyme which is induced in the livers of pregnant mice, Pi-aldehyde dehydrogenase (Pi-A1DH), is capable of metabolizing a form of vitamin B6, pyridoxal. It is likely that the development of seizures in pregnancy (eclampsia) is due partly to increased metabolism of vitamin B6 by Pi-A1DH. The experiments in this proposal are designed to test this hypothesis. Levels and turnover rates of the neurotransmitters (above) will be studied in regions of mouse brain during pregnancy. Blood levels of vitamin B6 will be followed and efforts will be made to relieve the deficiency of vitamin B6 by dietary supplementation with at least two forms of the vitamin. Lastly, attempts will be made to inhibit Pi-A1DH in vivo in an effort to halt the excessive metabolism of vitamin B6, and restore neuronal function and seizure susceptibility to normal. The incidence of preeclampsia and eclampsia have remained constant in pregnancy, and approximately 4% are affected to some degree. Eclampsia remains a major cause of maternal and neonatal morbidity and mortality. Since the cause of the disease is unknown, treatment is symptomatic, and methods of prevention are unknown. These studies should reveal the nature of the neurochemical changes which precede eclampsia and allow for a rational approach to the prevention of eclampsia.